Inquiry-Based Human Microbiome for Undergraduates in Distance Learning

Administrative Supplement: Curriculum or Training Modules to Enhance Undergraduate Biomedical Research Training (NOT-GM-20-019) Title: Inquiry-Based Human Microbiome for Undergraduates in Distance Learning ABSTRACT (from the funded parent award: MARC U-STAR GM008253-32) The SJSU MARC U-STAR program has been committed to support underrepresented students for nearly 30 years. As the new Program Director, Dr. Cleber Costa Ouverney, has inherited a dedicated cohort of trainees, a highly motivated group of mentors, and a committed administrative staff who endorse the mission of this prestigious NIGMS program in its entirety. Of the 167 trainees who have graduated from the program since 1988, 97% graduated with a BA/BS degree and 60% continued into a post baccalaureate degree (MS, PhD, or MD/PhD). The number of PhD-seeking trainees from our program has continuously increased over the six cycles of funding and we have 67 trainees who are either enrolled or have earned their PhD/MD- PhD degree. Nonetheless, areas of improvement to our program have been identified by the former PD (Dr. Leslee Parr), Dr. Ouverney, and the program evaluator and we address these improvements in this renewal application. Overall, this proposal combines goals that will retain the strengths the program has accumulated over decades while enhancing the recruitment and training of MARC trainees, while better tracking our MARC fellows' accomplishments for years to come. For instance, we included innovative approaches that establish collaborative work with the IRACDA postdocs from Stanford University who will provide additional mentoring to our trainees about various aspects of research projects, research presentation skills, and preparation of applications to graduate school. Our strong network with Summer Research Programs will serve as a bridge to our trainees to identify laboratories to conduct their summer research experience. We also propose to increase visibility of the program in our communities and have started to give talks at local school serving a large number of URM students about the opportunities for research training at SJSU, such as MARC, RISE and LSAMP programs. The strength of this program makes us certain that we can support a larger cohort of students and we are requesting an increase of MARC trainees from 9 to 12. A recent increase in hiring of faculty STEM tenure-track faculty and an increase in grants in the MARC hosting departments have made many new laboratories ready to host more MARC students.

Public health relevance
PROJECT NARRATIVE The primary goal of this Administrative Supplement (NOT-GM-20-019) to parent grant MARC U- STAR (GM008253-33) is to improve the academic preparedness and research training in biomedical research for undergraduate students in the MARC Program and in a keystone microbiology course (MICR101) at San José State University (SJSU). We are facing many challenges with potential detrimental effect in the success of our underrepresented students who have been particularly impacted by the coronavirus pandemic and the conversions our courses, teaching laboratories, and our research spaces to distance learning methods. The inquiry-based activities planned will engage students into a realistic research-based setting where we will apply modern molecular techniques and bioinformatics to better prepare our trainees and other students to be highly productive in biomedical science fields for many years to come.